Biomarker and Analytical Chemistry Core

Project Summery / Abstract: Biomarker and Analytical Chemistry Core
The PSU TCORS includes the three major interdisciplinary projects, pilot projects and educational activities
that will rely heavily on the use of analytical laboratory measurements for the assessment of tobacco products
and biomarkers analyses for the assessment of the effects of tobacco-related exposures on tobacco product
users and laboratory animal models of tobacco related harm. To support these activities, the Biomarkers and
Analytical Chemistry Core (BAC) will play a pivotal role. The BAC was established in 2013 as part of our
original TCORS and, since that time, has continued to support the Center activities by providing expertise for
study design, sample processing and analyses of tobacco products and related biomarkers, methods
development and data interpretation. We plan to continue with these activities to meet the needs of the
research to be conducted in the main and pilot project of the current proposal. As such, the BAC focuses on
the use of analytical chemistry and clinical chemistry methodologies supported by a strong expertise in
synthetic organic chemistry. The BAC activities will include the use of standardized analytical techniques and
instrumentation as well as the development of new analytical methods and design of novel instrumentation for
use with new and emerging tobacco products. In addition to supporting the research mission, the BAC will also
play a key role in the educational activities of the Center in collaboration with the Career Enhancement Core by
providing mentorship and training for TCORS postdoctoral scholars and teaching a 3-credit course on the use
of tobacco biomarkers (PHS 684 Biomarkers in Tobacco Research). The BAC will support the three major
projects, pilot projects, and educational activities by focusing on 8 specific aims. These include (1)
measurement of toxic and carcinogenic agents in tobacco products and their resulting smoke/aerosols; (2)
maintenance of experimental smoking laboratories with the capability of machine smoking/vaping a wide
variety of tobacco products for chemical analysis or animal exposure studies; (3) quantification of biomarkers in
biological samples from animal or clinical studies; (4) assessment of physical and chemical characteristics of
tobacco products; (5) preparation of synthetic standards required for chemical analyses; (6) processing and
archival of biological samples; (7) development of new methods and instrumentation for assessing tobacco-
derived agents in new and emerging products; and (8) training of TCORS investigators on the measurement
and use of biomarkers and their interpretation from both a research and regulatory perspective.